Training for the Multiscale and Multimodal Analysis of Biomarkers in Alzheimer's Disease

PROJECT SUMMARY/ABSTRACT
Recognizing the critical need for a broad range of expertise in biomarker analysis at several levels of analysis,
we propose a unique postdoctoral training program titled “Training for the Multiscale and Multimodal Analysis
of Biomarkers in Alzheimer's Disease” (AD). USC is home to leading experts who utilize biomarkers in their
work investigating AD through a myriad of methods and analyses. Drawing from USC's eminent resources and
expertise, this proposal will focus on preparing investigators for independent research careers in the multiscale
and multimodal analysis of biomarkers in AD, by integrating molecular and cellular methods, imaging tools and
informatics, quantitative methods for clinical trials research, and large scale population analyses. Our proposed
training program draws preceptors and faculty from six schools, departments, institutes, and centers at USC,
fulfilling these methodological areas of expertise: Mark and Mary Stevens Neuroimaging and Informatics
Institute (INI) in the Keck School of Medicine; Department of Biomedical Engineering (BME) in the Viterbi
School of Engineering; Zilkha Neurogenetic Institute (ZNI) in the Keck School of Medicine; Department of
Psychology in the Dana and David Dornsife College of Letters, Arts and Sciences; Leonard D. Schaeffer
Center for Health Policy and Economics, a unique collaboration between the USC Sol Price School of Public
Policy and School of Pharmacy; and Leonard Davis School of Gerontology. Trainees will complete coursework,
lab rotations, and career development activities, such as seminar series, instruction for problem solving,
communication, time management, and leadership skills, and instruction and training in grant writing. Trainees
will become conversant in all thematic areas and will be able to effectively collaborate outside of their own
particular area of expertise. Specifically, the USC Training for the Multiscale and Multimodal Analysis of
Biomarkers in AD will aim to: equip trainees with a combination of skills to conduct multiscale and multimodal
analyses of biomarkers in AD by providing tailored, didactic research education opportunities to further the
research potential of trainees; facilitate eminent research in the multiscale and multimodal analysis of
biomarkers in AD by trainees, including the development of research ideas, execution of research projects, and
dissemination of research findings; establish among trainees a collaborative and multidisciplinary team
approach to advance research in the multiscale and multimodal analysis of biomarkers in AD; and successfully
transition trainees to independent research careers, including securing their own research funding.

Public health relevance
PROJECT NARRATIVE USC's “Training for the Multiscale and Multimodal Analysis of Biomarkers in Alzheimer's Disease” (AD) will focus on preparing postdoctoral investigators for independent research careers by integrating four areas of methodologies to illuminate various aspects of biomarkers in AD at differing scales: molecular and cellular methods, imaging tools and informatics, quantitative methods for clinical trials research, and large-scale population analyses. Trainees will complete coursework and career development activities such as lab rotations, seminars, instruction for problem solving, communication, time management, and leadership skills, as well as career guidance, including instruction and training in grant writing, in order to apply successfully for future fellowships and career development and independent research support.